Activation of SIRT3 as a Therapeutic Strategy for Alzheimer's Disease

Background and Innovation: Alzheimer’s disease (AD) affects 10-15% of people after the age of 65. Around
50% of 21 million veterans, now in this age group, are disproportionately at a higher risk of developing AD.
Majority of veterans with AD have coexisting pathologies caused by diseases including, diabetes, hypertension,
and cardiovascular disease. Metabolic syndrome (MetS) is the precondition for these comorbidities.
Mitochondrial proteins are hyperacetylated in MetS leading to their decreased function. These protein
modifications are reversed by the deacetylase enzyme, known as SIRT3, the focus of this study. Studies on
SIRT3 function have generally remained in the domain of peripheral tissues. Our lab has made a significant
contribution to the understanding of SIRT3-regulated brain mitochondrial function with a series of key
publications. First, we observed brain mitochondrial dysfunction and inflammasome formation, a trigger for the
neuroinflammatory pathway in Sirt3-/- mice. Next, we generated APP/PS1/Sirt3-/- mice as a novel comorbid
mouse model with amyloid pathology and MetS. We observed in these mice that SIRT3 deficiency exacerbates
brain insulin resistance, neuroinflammation, amyloid plaque deposition and astrogliosis. Later, by RNA seq
analysis of brain samples, we demonstrated that the expression of insulin degrading enzyme (IDE), involved in
the regulation of insulin as well as degradation of Aβ, is decreased by ~50% following Sirt3 gene deletion.
Furthermore, by activation of SIRT3 with nicotinamide riboside in vivo and in vitro, we observed increases the
levels of IDE and neprilysin, another Aβ degrading enzyme and decreased the expression of BACE1, a key
regulatory enzyme in the generation of Aβ. Thus, targeting SIRT3 in AD is novel and innovative because of its
actions on key regulatory pathways where MetS and amyloid pathology interact.
Significance and Impact to Veterans Healthcare: Our findings suggest that not only SIRT3 activation
prevents the actions of MetS in the exacerbation of AD pathogenesis, but also directly ameliorate multiple
pathologies in the Alzheimer’s brain. Therefore, the central goal of current research project is to use genetic and
pharmacological approaches to test the effects of SIRT3 activation in Alzheimer’s mouse model and in cultured
primary microglia. Our recent studies have moved us further in this direction. First, we generated successfully
Sirt3 overexpressing mice in C57/BL6 background by a Cre-Lox system and observed upregulation of IDE in the
brain. In a parallel collaborative study, we tested the effects of a new class of potential drug molecules for the
treatment of AD, namely DCA and Hexa, synthetic analogs of honokiol, a naturally occurring SIRT3 activator.
These analogs have been characterized for their improved lipophilicity, bioavailability, and stability by our
collaborator, Dr. Arbiser (Emory University, Atlanta, GA). Based on our preliminary studies, we chose Hexa as
the most potent drug molecule for further investigation. Hexa improved mitochondrial respiration and decreased
neuroinflammation in in vivo and in cultured mouse primary microglia in a SIRT3 dependent manner. Our
proposed research is relevant and significant to the health care of Veterans. Therefore, outcomes of the
proposed proposal will contribute to the development of strategies to treat AD which is prevalent among veteran
population.
Path to translation/implementation: Herein, we will test the hypothesis that “SIRT3 has the potential to
ameliorate multiple key pathways of Alzheimer’s disease” with the following Specific Aims. Aim 1: To test
the efficacy of SIRT3 activator Hexa in decreasing Alzheimer’s pathologies in APP/PS1 mice. Aim 2: To
determine the effects of Sirt3 overexpression on brain transcriptome, metabolism, and insulin signaling in
APP/PS1 mice. Aim3: To determine how SIRT3 activation leads to improvement in microglial function. The
potential outcome of our proposed plan is that a novel pathway will be identified as a therapeutic strategy for AD
treatment which will have significant impact on veterans’ healthcare.

Public health relevance
Alzheimer’s disease (AD) affects 10-15% of people after the age of 65. Around 50% of 21 million veterans are now in this age group as they are disproportionately at a higher risk of developing AD. Majority of AD patients have other coexisting pathologies caused by diseases including obesity, diabetes and hypertension which are also prevalent among veterans. We have generated a new mouse model that mimics the features of AD with mixed pathology. With this model, we have shown that the deficiency of a protein called SIRT3 aggravates AD by increasing brain inflammation and amyloid plaque deposition. Currently, there are no drugs available to reverse or delay AD progression. Honokiol is a naturally occuring SIRT3 activator. We have demonstrated that synthetic honokiol anlogs are more active than honokiol. We will further investigate the effects of this new class of drug molecules in Alzheimer’s mouse models in this proposal.